Therapeutic Targeting of Breast Cancer Tumor Initiating Cells

PROJECT ABSTRACT
Triple Negative Breast Cancer (TNBC), if considered its own disease type, would rank as the 5th leading cause
of cancer deaths in women in the USA. The main systemic treatment option for these patients in the adjuvant
setting is multi-agent chemotherapy, and now since early 2019, immunotherapy plus chemotherapy is an option
for PDL1-positive metastatic patients. TNBC is also known to be biologically heterogeneous, with multiple
genomically-defined subtypes present. We hypothesize that much of this heterogeneity actually represents
cellular plasticity, and that some TNBC subtypes can actually morph from one subtype into another. We
hypothesize that this plasticity is a key determinant of chemotherapy responsiveness, immune checkpoint
inhibitor sensitivity, and metastatic potential. Furthermore, we hypothesize that if we are able to keep, or promote,
a tumor into the basal-like state, there may be both a change in the immune microenvironment and increased
therapy sensitivity. We will test these hypotheses by using novel combinations of drugs, in vitro screens, and in
vivo testing of metastasis vs primary tumor sensitivity using Genetically Engineered Mouse models and human
tumor specimens.

Public health relevance
PROJECT NARRATIVE Breast cancer is the most frequent type of cancer that occurs in women (>200,000 cases/year) and accounts for ~40,000 deaths each year in the United States. Triple Negative Breast Cancers (TNBC) are an important clinical subtype because they lack the three known important therapeutic targets used in the breast cancer clinic, namely the Estrogen Receptor, the Progesterone Receptor, and the HER2 protein. In this application, we propose to study the chemotherapy and immunotherapy responsiveness of TNBC and explore the hypothesis that much of the therapy resistance seen is due to a tumor's ability to change from one type of cellular “state” into a more resistant “state”. We hypothesize that we can prevent these state changes using drugs that interfere with DNA structure changes, therefore possibly identifying new therapeutic interventions that might overcome drug resistance in TNBC patients.